Automated microfluidic hyperpolarization reactor for neurometabolic imaging

Abstract
Brain function is regulated by molecular signaling and metabolism, however, our ability to track neurometabolic
transformations deep in the brain is very underdeveloped compared to the central role of neurometabolism in
neurodegenerative disease or brain function in general. In this Phase I SBIR, it is our goal to establish and refine
emergent hyperpolarization technology as an inexpensive, sturdy and reliable neurometabolic imaging tool that
can be disseminated and applied broadly.
Current molecular imaging approaches, for example PET/SPECT, require an immense infrastructure and
are not broadly applicable. In this proposal we will produce, test and refine two hyperpolarization units that allow
for molecular imaging at low cost at any research facility. Specifically, the hyperpolarizers deliver safe, injectable
solutions of endogenous metabolites that carry hyperpolarized nuclear spins, which are detected using any MRI
system. The hyperpolarization enhances the MRI signals by 4 to 7 orders of magnitude and reports directly on
the molecular transformations in study subjects. Hence direct imaging of molecular pathways in the living subject
is enabled.
The objective of this proposal is to make existing hyperpolarizer prototypes sturdy and easy to use.
Simultaneously, we aim for pilot installations at pre-clinical sites in order to test the prototype’s ability to integrate
with pre-clinical workflows. With successful completion this Phase I SBIR we will have a sturdy and easy-to-use
hyperpolarizer that makes hyperpolarized MRI accessible to the neuroscience research community and enables
non-invasive imaging of metabolic dysregulation during the earliest stages of disease. In turn the established
devices and workflow lead to new insights into molecular pathology and to preclinical testing of novel
interventions and drugs.

Public health relevance
Project Narrative / Public Health Statement In this Phase I SBIR, we develop and mature metabolic imaging technology that enables non-invasive detection of early molecular pathophysiology, well before anatomical and physiological correlates are measurable. This is a significant innovation because neurometabolic disturbances typically precede disease symptoms. Current state-of-the-art technologies -- direct examination of brain tissue and molecular imaging -- are problematic and very costly. In contrast, with the imaging approach proposed here, neurometabolic dysregulation can be detected non-invasively and well before physiological effects become apparent. Our approach provides the neuroscience research community (and beyond) a non-invasive imaging modality to probe neurometabolic disturbances and is expected to lead to novel scientific insights as well as new diagnostics and interventions.